Defining targetable vulnerabilities in UBA1-mutated VEXAS HSCs for clonal eradication

ABSTRACT
The expansion of somatically mutated clones is prevalent in hematopoiesis with profound implications for
physiological aging and across a myriad of pathologies. This has been recently highlighted by the discovery of
the inflammatory disorder – vacuoles E1 enzyme X-linked autoinflammatory somatic (VEXAS) syndrome.
VEXAS is caused by somatic mutation in the ubiquitin-activating enzyme E1 (UBA1) gene that arises in
hematopoietic stem cells (HSCs). Mutated UBA1 leads to accumulation of misfolded proteins, activation of the
unfolded protein response and ultimately systemic inflammation accompanied by severe clinical manifestations.
However, we currently lack the ability to target disease-initiating mutant HSCs, as the mechanisms that lead to
HSC inflammation, differentiation bias and survival are unknown. This limitation stems in part from the fact that
somatic clones are admixed with wild-type HSCs, limiting the ability to define mutant-specific phenotypes with
either bulk or single-cell techniques. To overcome this gap, we have developed genotype-aware single-cell multi-
omics techniques that are specifically designed to map somatic genotypes to phenotypes. These tools turn the
limitation of admixed mutated and wild-type cells into an advantage, allowing for direct comparison in primary
human samples of mutated cells to wild-type cells residing within the same bone marrow environment. Our proof-
of-principle studies demonstrated that we can leverage these tools to pinpoint UBA1 mutation-specific HSC
perturbation, that can be leveraged for selective targeting. Our preliminary data show that UBA1-mutant HSCs
have increased upregulation of the unfolded protein response pathway through PERK activation, suggesting a
compensatory mechanism for mitigating proteomic stress to promote survival in mutant cells where normal
protein degradation is disrupted, which we validated in vitro. Moreover, this approach enables the
characterization of how the impacts of a somatic mutation vary as a function of cell type, providing insights into
mechanisms of clonal outgrowth that cannot be obtained through bulk analysis. Here, to test the hypothesis that
UBA1-mutant HSCs resist proteome toxicity via dysregulated signaling pathways, we will directly analyze VEXAS
primary patient samples using single-cell multi-omics to map the impact of UBA1 mutations on HSC chromatin
profiles, gene expression and protein expression. Moreover, given the critical role of the bone marrow niche on
HSC biology, we will apply advanced tools for spatial transcriptomic profiling to identify candidate cell-extrinsic
mechanisms supporting mutant HSC survival, defining altered cell-cell interactions in VEXAS syndrome. Finally,
we will use new in vitro and in vivo model systems to mechanistically interrogate and functionally validate key
factors that promote disease phenotypes, representing potential targets for the development of novel precision
treatments. Collectively, these efforts and new techniques will provide novel insights into VEXAS biology, and
further provide a framework for deciphering the critical factors that are disrupted in disease-initiating cells and
the microenvironment in somatic mosaicism and hematological disease more broadly.

Public health relevance
PROJECT NARRATIVE The recently described non-malignant blood disorder VEXAS (vacuoles E1 enzyme X-linked autoinflammatory somatic) syndrome results in severe systemic inflammation with diverse clinical symptoms, stemming from the emergence of mutation in a key enzyme regulating protein turnover in blood stem cells. However, the precise molecular mechanisms driving this disease remain poorly characterized, hindering the development of effective treatments, which currently are lacking. Here, to broadly explore the fundamental mechanisms of somatic evolution in the blood system and unravel the alterations that are driving disease pathology in mutant cells and the bone marrow environment in VEXAS, we will apply single-cell and spatial analysis directly to human samples, followed by functional interrogation using novel disease models, to identify key factors underlying VEXAS phenotypes that could potentially be targeted with precision therapies that eliminate the disease-initiating cells.